Seniors Oral Health in Southeast Alaska

SUMMARY
The increase in longevity, reduction in tooth loss, increase in periodontal diseases and coronal and root
dental caries with aging are contributing to an increased number of seniors with oral health care needs.
Dental caries and periodontal diseases disproportionately affect Alaska Native older adults: they are 3 times
more likely to have untreated dental caries and 1.7 times more likely to have periodontal disease than the
overall United States population. Prospective studies on the prognosis of these oral disorders are lacking,
particularly those deconstructing racial and ethnic differences. The goal of this research project is to
understand outcomes of geriatric patients with periodontal diseases and/or dental caries and identify
prognostic factors for success in disease control, with a focus on Alaska Native seniors.
Our primary aim is to estimate, separately, 36-month success rates for periodontitis and dental caries
management for geriatric patients overall, and for Alaska Native/American Indian seniors. Our secondary aims
are 1) to ascertain practitioner-, patient-, oral environment- and tooth-level prognostic characteristics
associated with 36-month successful disease control strategies; and 2) to describe initial disease diagnosis
and management strategies used by practitioners, and associated factors.
We will accomplish these aims by conducting a prospective cohort prognosis study within a tribal healthcare
organization serving urban and remote rural geographical locations in Southeast Alaska. In this observational
study, approximately 600 patients with periodontitis and/or dental caries will be systematically enrolled and
followed up for three years. Data on oral health, patient, and provider characteristics as well as diagnosis and
disease management strategies will be collected at baseline, and yearly up to 3 years after enrollment. This
study is innovative and highly relevant to public health and clinical research because it addresses the lack of
rigorous prospective US practice-based geriatric oral health research, and the uncertainty in prognosis and
prognostic factors when managing oral disorders in patients suffering the greatest oral health disparities.
Through prognosis research, we can gain important knowledge on how to potentially improve clinical decision
making for better Alaska Native geriatric oral health.

Public health relevance
NARRATIVE This is a five-year grant application for a prospective observational clinical study to assess the prognosis of periodontal disease and dental caries management of seniors, including Alaska Native seniors. This is relevant to public health and clinical research because rigorous assessment of periodontal disease and caries management prognosis will lead to a dental workforce better prepared to treat seniors in general, and American Indian and Alaska Native seniors, in particular; and thus help the aging population enjoy better oral health. The proposed research addresses NIDCR strategic plan's goals to apply rigorous, multidisciplinary research approaches to overcome disparities and inequalities; support best science; enable precise and personalized health care through research; and ensure a strong research workforce dedicated to improving dental, oral and craniofacial health.